Immune Regulatory Roles of Endothelial Cells in Neonatal Heart Regeneration

Project Summary
Heart failure (HF) is the long term effect of the mechanical stress and chronic inflammation that occurs
following an acute ischemic event in cardiac tissue. Current pharmacological agents can only manage the
symptoms of HF, and are not reparative. Importantly, cardiovascular disease perpetuates as the leading cause
of death worldwide. Therefore, it is crucial to elucidate the mechanisms that govern cardiac injury responses in
order to realize effective HF therapies. Although extensive studies have strongly focused on the replenishment
of cardiac muscle cells, cardiomyocytes, it has been shown that other cell types in the heart, including resident
immune cells and endothelial cells (ECs), are also essential for maintaining tissue homeostasis and orchestrating
injury responses. Thus, understanding how these different cardiac cell types govern the injury response leading
up to HF is crucial for combatting this deadly disease.
Adult mouse myocardial infarction (MI) models of left anterior descending arterial occlusion (LAD-O) exhibit
very similar cardiac remodeling to the failing human heart. However, neonatal mice less than 8 days old possess
a robust regenerative capacity when subjected to MI and are able to achieve an almost complete functional
recovery with scar resolution. Our preliminary single-cell RNA sequencing (scRNA-seq) data uncovered a unique
endothelial cell population that emerges post-MI in regenerative postnatal day 1.5 (P1.5) hearts but not in non-
regenerative P8 hearts. Moreover, immune cells such as macrophages are expanded in the heart during an
injury response to promote a pro-reparative environment. Transcriptome analysis of this regenerative EC
population revealed an immune signature, suggesting that ECs may facilitate a pro-regenerative immune
response via direct myeloid cell recruitment. The objective of this study is to determine the role of ECs in heart
regeneration. Given the above findings, we therefore hypothesize that neonatal cardiac regenerative endothelial
cells (rECs) promote regeneration by expanding a pro-reparative immune cellular composition.
Utilizing mouse genetics and multi-omics, we aim to uncover the role of rECs and their immune signature in
cardiac regeneration. We will study whether rECs expand local reparative immune cells to promote mammalian
cardiac regeneration utilizing a combination of in vitro culturing experiments and in vivo transplantation studies.
We will then further investigate whether the immune signature of rECs facilitate mammalian heart regeneration
by promoting the expansion of reparative macrophages after MI utilizing mouse genetics and in vivo gene editing.
These experiments will provide novel insights into how rECs regulate regeneration and help uncover new
therapeutic targets in immunomodulation for heart failure.

Public health relevance
Project Narrative Numerous studies have shown that cardiomyocytes can be replenished following cardiac injury to promote regeneration; however, it has been recently shown that in addition to cardiomyocytes, other cell types such as immune cells and endothelial cells (ECs) are necessary for cardiac regeneration. In this proposal, we aim to bridge the gap between endothelial cells and the reparative immune system by investigating regenerative endothelial cells (rECs) that arise exclusively during the cardiac regenerative injury response. We will identify the genes that distinguish rECs during the regenerative stage, paving the road for therapeutic modalities that target ECs to treat heart failure.